The role of microglia in major depressive disorder

Major depressive disorder (MDD) is a common mental illness that affects more than 300 million people
worldwide. Depression is the most prevalent mental illness among U.S. veterans and increases their risk of
hospitalization and death. Also, the prevalence of depression in veterans is significantly higher than in general
U.S. adult population. Available treatments are ineffective for many MDD patients, and there is an urgent need
to obtain a better understanding of biological bases of MDD in order to develop novel therapeutic strategies.
Genetic contribution to MDD is ~40%, and recent large-scale GWAS discovered 102 significant loci that
are linked to MDD risk. However, as in other complex disorders, the majority of the MDD risk loci reside within
non-coding regions of the genome and are predicted to alter the activity of gene regulatory elements (GREs;
e.g., enhancers or promoters). In addition, the effect of a GRE on gene expression is frequently dependent on
the cell and tissue type, making it a challenge to understand the functional impact of GWAS risk loci. Linking
the disease risk variants with expression quantitative trait loci (eQTLs) and/or with epigenetic maps of GREs in
relevant tissues/cell types yielded formidable results in other psychiatric diseases and holds promise for MDD.
In addition, a systematic experimental validation of eQTLs/enhancers’ activity via massively parallel reporter
assays (MPRAs) provides a powerful platform to decipher the functional impact of the disease risk variants.
To date, many neurobiological studies of MDD have been concentrated on neuronal dysfunction.
However, multiple studies implicate microglia (MG)—the immune cells of the brain—to the pathogenesis of this
disorder. Our preliminary data shows that MDD genetic risk is reflected in gene expression changes in the blood-
derived myeloid cells. Because of the substantial overlap in transcriptomes of these cells and MG, these data
suggest that MG might play an important role in susceptibility to MDD. However, large-scale gene expression
data in purified MG are not available to test this hypothesis.
Our overarching goal is to discern MG dysfunction in MDD as well as to link this dysfunction to genetic
predisposition to MDD by integrating MDD GWAS, MG eQTLs, and epigenetic maps of enhancers that are active
in MG. In Aim1, we will use our novel fluorescence-activated nuclei sorting (FANS) protocol (which allows the
separation of MG from autopsied human brain) to generate high-quality gene expression data in MG purified
from a large cohort of MDD cases and controls (N~300). Importantly, the cohort includes specimens from the
U.S. veteran population. We will also perform a case-control comparison of gene expression in MG, including
testing if alterations in MDD are different in veterans vs. non-veterans, In Aim2, we will use gene expression data
from Aim 1 to map MG eQTLs, and will integrate these eQTLs with MDD GWAS findings using rigorous
computational approaches. These analyses will unravel the functional implications of MDD risk variants on gene
expression in MG, and will identify candidate causal eSNPs that will be functionally validated in Aim 3. Finally,
in Aim3, we will use MPRAs to validate the candidate causal eSNPs that are harbored by putative enhancers
and/or eQTL regions in MG. MPRAs will be performed in MG-like cells that will be differentiated from human
induced pluripotent stem cells.
Collectively, the proposed studies will lead to the discovery of MDD risk variants and the affected genes
that are likely to be causal for MDD and act specifically in MG cells, paving the way for the development of novel
treatment approaches. These studies are especially important for U.S. veterans, as the surge of depression-
related suicides among veterans necessitate the development of novel therapeutic strategies for MDD.

Public health relevance
Major depressive disorder (MDD) is a neuropsychiatric illness with considerable morbidity, mortality (including suicide), and personal and societal cost. Available treatments are ineffective for a large subset of MDD patients, and even among patients who respond to treatment only a fraction show long-time remission. Thus, there is the strong need to use novel approaches to advance our understanding of the biological bases of MDD in order to develop more efficacious treatments, which is an overarching goal of this application.